Mechanisms of stimulus-induced network focusing

Project Summary
Large-scale recordings are discovering that individual neurons in sensory, cognitive, and motor networks often
participate variably, even when presented with identical inputs. The reason for such variability is unclear, and
an active topic of debate in the field. Does it reflect randomness in neuronal participation, or is it an adaptive
feature that plays an essential role in healthy brain function? The scientific premise of this application is the
latter—that variably participating neurons reflect the operation of a “focusing” mechanism innate to many
networks that allows them to rapidly and flexibly rearrange which neurons are called upon to process specific
information in the context of the moment.
This hypothesis emerged unexpectedly from our large-scale recordings of the rhythmic escape swim network of
the marine mollusk Tritonia diomedea. We were surprised to discover that during the initial seconds of
responding to an unexpected aversive sensory input, Tritonia's swim motor program rapidly tunes itself, pulling
many initially-silent neurons into the bursting population and driving others out, apparently optimizing itself for
escape. In this Tritonia case, the “focused” state is then maintained for several minutes, enabling a stronger,
faster-onset motor program should the same stimulus recur. Many studies in vertebrates have reported rapid
growth in the size of responding networks with repeated stimulation, but the mechanisms and purpose of such
phenomena are poorly understood.
This project's goal is to uncover the mechanisms underlying what may be an important versatility process for
healthy function in many brain networks—one that allows them to rapidly re-allocate neurons to suit a specific
context, and then hold that focused state for a sustained period of time. The project has 2 Specific Aims: Aim
1 will map the re-allocating neurons and address several issues regarding the phenomenology of this poorly
understood network focusing process. Aim 2 will determine the cellular mechanisms driving the rapid re-
allocation of neurons into and out of the bursting escape swim network as it focuses. The principles of rapid
network focusing to be investigated here may promote novel approaches for treating or preventing declines in
cognitive function in aging and disease.

Public health relevance
Narrative Understanding the mechanisms governing how the brain flexibly adjusts it networks to process rapidly changing stimuli is of enormous human health significance. The short term goal of this proposal is to investigate the mechanisms by which neurons are rapidly reallocated to and from active networks depending on the stimulus of the moment. Our long term goal is to use the insights gained from this study to stimulate new approaches and perspectives for understanding and treating cognitive decline associated with aging and disease.